Simultaneous Alcohol and Marijuana Use: Momentary Influences and Consequences

Project Summary/Abstract
The research plans and tailored training activities proposed in this Mentored Research Scientist Development
Award (K01) application will enable the Candidate, Dr. Ashley N. Linden-Carmichael to develop essential skills
to build her program of research and transition to independence as an alcohol investigator. Dr. Linden-
Carmichael’s work uses innovative methodological and statistical techniques to gain an in-depth understanding
of high-risk drinking patterns exhibited by young adults. The current application builds upon her previous work
as a National Research Service Award (NRSA; F31) pre-doctoral fellow by studying an emerging public health
concern: simultaneous alcohol and marijuana (SAM) use (i.e., using alcohol and marijuana at the same time).
SAM use is particularly problematic because the use of both substances can interact to produce a synergistic
effect on impairment. The proposed research activities aim to fill several gaps in our basic knowledge of SAM
use by providing detailed, momentary information on the predictors and consequences of SAM use patterns
through the innovative use of wearable alcohol sensors and ecological momentary assessments. Specifically,
the two studies proposed aim to better understand SAM use patterns by (1) developing a brief measure of
SAM use motives for use in ecological momentary assessment (EMA) surveys; (2) using EMA to identify
person-, day-, and moment-level predictors of SAM use; (3) applying novel intensive longitudinal data methods
to characterize dynamic features of alcohol intoxication within SAM and alcohol-only use episodes; and (4)
comparing day-level consequences of episodes of SAM use versus use of either substance alone. This
research will be conducted in The Edna Bennett Pierce Prevention Research Center at The Pennsylvania
State University, an ideal and thriving research institution that will provide the Candidate with all of the
resources she needs to carry out her research agenda and training goals. The Candidate will be mentored by
an interdisciplinary team of experts with unique and overlapping skillsets: Dr. Stephanie Lanza (expert in
intensive longitudinal data analysis), Dr. Jennifer Maggs (expert in theoretical frameworks for substance use
across the lifespan), Dr. Joshua Smyth (expert in EMA methodology), and Dr. Emily Ansell (expert in
momentary marijuana assessment). The career development plan outlined in this K01 application will allow the
Candidate to obtain essential training on (1) problematic substance use behavior among young adults, (2)
assessing high-risk drinking behavior and its correlates in the moment, (3) analyzing complex intensive
longitudinal data, and (4) producing high-impact papers and successful grant applications to advance
leadership in co-use. The research plan and training activities will facilitate Dr. Linden-Carmichael’s long-term
career goal of building an independent program of research focused on understanding and intervening on
problematic substance co-use patterns among young adult drinkers.

Public health relevance
Project Narrative Young adults who use alcohol and marijuana at the same time are more likely to drink heavily and experience negative outcomes (e.g., blacking out from drinking), yet little is known about the contextual and individual risk factors that contribute to simultaneous alcohol and marijuana (SAM) use. The current project will use innovative technologies (wearable alcohol sensors and ecological momentary assessment) to understand SAM use patterns that unfold in context and in real time. Findings will help identify the predictors and consequences of problematic SAM use behavior, informing a new generation of interventions for high-risk young adult drinkers.